Extracellular vesicle-based intraocular therapy combined with active targeting of ocular neovascularization

Abstract (Parent Award)
Intravitreal injection of anti-vascular endothelial growth factor (VEGF) agent monotherapy is the current mainstay
for treating neovascular age-related macular degeneration (NVAMD). Despite its vision saving benefit, some
patients fail to respond to the treatment because of insufficient therapeutic effect and/or the socioeconomic
burden of frequently required repeat injections. Therefore, the long-term goal of our studies is to develop superior
or adjunctive approaches to the current anti-VEGF therapy that can provide active targeting of NVAMD, have
the capacity to deliver multiple drugs, and maintain long-term efficacy. Exosomes are naturally occurring, cell
secreted, and nano-sized extracellular vesicles. Exosomes carry various cargos including microRNAs, proteins,
and lipids for cell-to-cell communications. Recently, we have shown that intravitreally delivered ASL-exosomes
composed of Anchor, Spacer, and Arg-Gly-Asp acid (RGD) Ligand-modification actively target choroidal
neovascularization (CNV) with adequate retinal penetration. The unique nature of exosomes and our study
demonstrate great promise in exosomes as the next regeneration intraocular drug delivery system. However,
the accelerated translation to humans has been hindered due to a lack of clarity as to mechanisms of exosome
uptake within the retina thus preventing a standardized formulation and an optimized therapeutic application of
exosomes. The objective of the current studies is to elucidate the extracellular and intracellular mechanisms by
which ASL-exosomes actively target ocular NV and to use this information in optimizing this drug delivery system
for simultaneous delivery of Aflibercept and miR-24 to suppress ocular NV and its secondary fibrosis through
independent pathways. Our proposed studies will test the hypothesis that intravitreally delivered ASL-exosomes
allow their targeted delivery to ocular NV lesions through active binding to increasingly expressed
transmembrane integrins at NV sites and through increased intracellular uptake of exosomes by integrin
receptor-mediated intracellular endocytosis. Further, we hypothesize that the ASL-exosome system that is
complemented with active targeting and sustained multi-drug delivery capacity with minimal immune responses
can effectively suppress NV and fibrosis by co-delivering Aflibercept and miR-24, a new intracellular target for
retinal fibrosis. The central hypothesis will be tested by pursuing three specific aims. Aim 1 is to determine the
mechanism by which ASL-exosomes actively target ocular NV. Aim 2 is to optimize the formulation of multi-
drugs loaded ASL-exosomes. Aim 3 is to determine sustained multi-drug delivery using exosomes and related
immune responses. The research proposed in this application is innovative because the combination of an
exosome-based intraocular drug delivery system with active targeting is a novel strategy that has the potential
to change the current treatment paradigm from passive targeting-directed monotherapy to active targeting-
directed multi-drug delivery with sustained efficacy for the treatment of various retinal and choroidal vascular
diseases.

Public health relevance
Project Narrative (Parent Award) The proposed research is relevant to public health because it focuses on developing a new treatment strategy, an extracellular vesicle (exosome)-based novel intraocular drug delivery system providing active targeting of ocular neovascularization, capacity to deliver multiple drugs, and sustained efficacy to treat neovascular age- related macular degeneration (NVAMD), a leading cause of blindness in people older than 60 and a major increase in healthcare cost. Development of these strategies has great potential to upgrade the therapeutic efficacy, and to reduce the treatment burden by shifting the paradigm in ocular drug delivery from current passive targeting directed monotherapy to active targeting-directed multi-drug delivery with sustained efficacy for the treatment of NVAMD as well as other posterior eye diseases.